Impact of Payment Models and Legislation on Gender Affirming Surgery

Project Summary
An estimated 1.4 million Americans identify as transgender, defined as incongruence between one’s gender
and their gender assigned at birth. For many transgender people, having primary and secondary sex
characteristics that align with their gender is essential to mental, emotional, and physical wellbeing as well as
their ability to meaningfully engage in social roles. Gender-affirming surgery allows patients to change their
primary and secondary sex characteristics through a variety of operations, including vaginoplasty, phalloplasty,
gender-affirming mastectomy, breast augmentation, and facial feminization. The number of individuals seeking
gender-affirming procedures has increased dramatically in recent years, with over 8,000 gender-affirming
procedures performed in the United States in 2017 alone.
Despite their effectiveness, gender-affirming procedures are costly, and often prohibitively expensive for most
patients without insurance coverage. Fortunately, many insurance carriers provide coverage for gender-
affirming procedures, but most require prior authorization processes and do not offer uniform coverage for all
types of procedures. Further, coverage for these procedures varies geographically, and depends on both state
and federal legislation. As such, the effects of policy and payment models on the accessibility of gender-
affirming surgery remains unclear. In this two-year study, we will quantitatively and qualitatively examine the
impact of legislative measures and payment models on the rates of gender-affirming surgery. We specifically
aim to: 1) assess the effect of payment models on access to these operations via the patient perspective and
2) utilize claims database analysis to determine the association of the enactment of the Affordable Care Act
and rates of gender-affirming surgery. Results from this mixed-methods investigation are critical to evaluating
the efficacy of policy affecting gender-affirming surgery and guide future legislation. The robust methodology
proposed in this study alongside the rigorous coursework through the National Clinician Scholars Program will
prepare Dr. Lane for a career as a surgeon-scientist with deep expertise in the application of health services
research to enhance the care of transgender individuals.

Public health relevance
Using both qualitative and quantitative methodology, we will examine patient-perceived and population-based barriers to gender affirming surgery. We will perform semi- structured interviews to evaluate financial toxicity as well as claims database analysis to determine the effect of insurance characteristics and federal policy on the rates of gender affirming surgery.